The role of MAP3K2/3 in modulating neutrophil ROS release and its translational potential

Project Summary:
The long-term goal of my lab is to understand the signaling mechanisms by which chemoattractants regulate
neutrophil functions and their roles in inflammation-related disease models. Chemoattractants stimulate
production of reactive oxygen species (ROS) from neutrophils. ROS is chemically reactive and used by
neutrophils to eliminate pathogens. It also exerts significant impact on the hosts. Most studies have shown that
increases in ROS production are responsible for tissue damage that exacerbates disease conditions including
many of the inflammation-related diseases. However, recent evidence, especially human genetic evidence,
suggest that ROS's role may be much more complex than previously believed; it also plays a protective role. In
the preliminary study of this application, we found that MAP3K2/3 can phosphorylate a key component of
NADPH oxidase complex, which is a protein responsible for ROS generation in leukocytes. The elimination of
MAP3K2/3 in leukocytes leads to increased generation of ROS and reduced lung damage in two mouse acute
lung injury models, which is diminished by inhibiting ROS generation. We thus hypothesize that deactivation of
MAP3K2/3 protects the lung against acute injury through a moderate increase in ROS release from leukocytes.
In this study we will investigate the signaling mechanisms by which MAP3K2/3 inhibits ROS generation. We
will also characterize how MAP3K2/3 inhibition reduces lung damage during acute lung injury and evaluate the
therapeutic potential of a MAP3K2/3 inhibitor in mouse acute lung injury models. Acute lung injury (ALI) and its
more severe form, acute respiratory distress syndrome (ARDS), in which leukocytes play an important role, are
common syndromes with a high mortality rate with no effective pharmacological treatments. Thus, our study
not only exerts strong impact in understanding of signaling mechanisms for ROS production regulation, but
also may have an important clinical implication.

Public health relevance
Project Narrative: Reactive Oxygen Species (ROS) released from neutrophils has been shown to play an important role in acute lung injury, a condition that is associated with high morbidity and mortality and lacking effective pharmacological treatments. This study intends to determine the key molecules and mechanisms for the regulation of ROS production by neutrophils and to investigate whether these molecules may be suitable therapeutic targets for the treatment of the disease in a mouse model. Thus, this study may lead to new therapeutic strategies and approaches to this and other inflammation-related diseases.